UMN VDL Infrastructure Support to Build and Support Capacity to Respond to Animal Foodborne Outbreaks

Project Abstract:
The University of Minnesota (UMN) Veterinary Diagnostic Laboratory (VDL) has the capacity
and the opportunity to support the investigation of animal foodborne illness through the FDA
CVM Vet-LIRN program, most specifically in the area of bacterial contamination.

Public health relevance
Project Narrative: The VDL will support the Vet-LIRN through participation in FDA/Vet-LIRN sample analysis in the event of an animal food/feed contamination event, providing analytical data to FDA for potential regulatory use, and participation in additional projects, i.e. method development and validation as determined and directed by the VPO. The VDL will maintain its infrastructure for diagnosis of bacterial contamination in order to provide this support.